Marmosets as a Model for Understanding Social, Neuroendocrine, and Vascular Contributions to Cognitive Aging

Project Summary
The number of U.S. residents over age 65 is projected to be 98.2 million by 2060, comprising
approximately 1 in 4 U.S. residents. According to the Pew Research Center, approximately 26%
of older adults live alone. While loneliness does not necessarily correlate with living alone, more
than 40% of seniors regularly experience loneliness. Loneliness is thought to accelerate
cognitive decline in older adults, possibly mediated through rising glucocorticoid levels and
increasing inflammation. There is a “great unmet therapeutic need” for the development of
cognitive therapeutics for the treatment of neurocognitive disorders associated with aging
including dementias and Alzheimer’s disease. Identifying characteristics of animal models that
may contribute to the development of such a cognitive therapeutic would have significant
impact. Common marmosets are poised to become an important nonhuman primate model in
the study of age-related disease. The focus of this research is healthy brain aging, and the
social, neuroendocrine, and vascular contributions associated with normal aging rather than
disease states. The population will be characterized using standardized cognitive assessments
to define those that have good vs poor cognitive aging. The likelihood of the following variables
as determinants of cognitive aging outcomes will be modeled: sex, social history, current
housing condition, cerebral blood flow (imaging assessments), and myelination. Aim 1 will focus
on assessing whether social support buffers the effects of stress on cognitive and
neuroendocrine function during aging. An experimental manipulation of a period of separation of
a long-term pair, then reunion, will allow us to investigate the role of social buffering on cognition
and examine how quality of the social support affects cognition and regulation of the HPA axis.
Aim 2 will focus on identifying vascular contributions to aging. We will assess cognitive
performance and cerebral blood flow (CBF) by arterial spin labeling in aged and geriatric
marmosets. We expect cognitive outcomes will be positively correlated with CBF and brain
vascular density. Aim 3 will determine whether changes in white matter integrity are associated
with cognitive dysfunction. The results of this study will contribute novel insights and deeper
understanding of the role of social stress and neuroendocrine disruption in age-associated
cognitive dysfunction. We anticipate that identifying these links will fundamentally advance
research in the study of aging, and may advance the establishment of the marmoset as a highly
translational model of these conditions.

Public health relevance
Project Narrative The objective of the proposed research is to examine social, neuroendocrine, and brain microvascular contributions to age-related cognitive changes. These results will markedly advance our understanding of cognitive aging in marmosets, its etiology, and the potential of this NHP species as a model of brain aging. The results of this study will also contribute novel insights and deeper understanding of the role of social stress and neuroendocrine disruption in age-associated cognitive dysfunction.